Genomic and physiological mechanisms of hypoxia adaptation in high-altitude mice

PROJECT SUMMARY
High-altitude animals have evolved the ability to survive and function under conditions of oxygen deprivation
(hypoxia) that mimic disease states in humans. Identifying evolved mechanisms of hypoxia adaptation in
mammals that are long-term high-altitude natives can therefore yield discoveries of biomedical relevance while
also providing general insights into the evolution of complex traits. A number of wild rodent species inhabit far
more extreme altitudes than Tibetan and Andean humans and also represent far more tractable subjects for
experimental approaches that involve genetic crosses and invasive physiological manipulations. This project
integrates genomics and experimental physiology to dissect the mechanistic basis of adaptive enhancements of
whole-animal performance in hypoxia in extreme high-altitude rodents. The experiments compare high- and low-
altitude populations of two species: the deer mouse (Peromyscus maniculatus), which has the broadest
altitudinal range of any North American mammal (sea level to 4350 m), and the Andean leaf-eared mouse
(Phyllotis vaccarum), an extremophile species that holds the record as the world’s highest dwelling mammal and
that also has the broadest altitudinal range (sea level to >6700 m [>22,000’]). To test hypotheses about adaptive
regulatory responses to hypoxia, we will use a common-garden experimental design to integrate measures of
whole-animal physiological performance (aerobic exercise capacity in hypoxia) and various subordinate traits
(respiratory, cardiovascular, and metabolic) with tissue-specific transcriptomic and metabolomic profiles.
Experiments will involve highly invasive manipulations (e.g., surgical instrumentation of arterial and venous
catheters to measure blood gases during exercise trials and terminal sampling of vital organs) that are not
feasible in human subjects. In both species, mechanistic experiments will be complemented by population
genomic experiments to generate hypotheses about the specific genes and pathways that may have contributed
to hypoxia adaptation. Such hypotheses will then be tested using follow-up experiments to measure phenotypic
effects of changes in gene function and/or gene expression, as illustrated by our ongoing work on deer mice.
The specific aims of the research are (1) to elucidate the mechanistic basis of adaptive enhancements of aerobic
performance capacity in hypoxia; (2) to determine how regulatory changes in gene expression translate into
changes in phenotype at different hierarchical levels of biological organization; and (3) to identify and
experimentally test new candidate genes and pathways for hypoxia adaptation. The integration of population
genomics, functional genomics, and experimental physiology will advance the field by elucidating the
mechanistic basis of adaptive evolutionary change in complex performance traits.

Public health relevance
PROJECT NARRATIVE High-altitude mammals have evolved exquisite physiological adaptations to survive and function under conditions of chronic oxygen-deprivation (hypoxia) that mimic disease states in humans. For this reason, identifying and characterizing evolved mechanisms of hypoxia adaptation in high-altitude mammals may provide insights that guide the design of novel therapeutic interventions for patients suffering from various forms of metabolic or cardiorespiratory diseases. The goals of this research project are to elucidate the mechanistic basis of hypoxia resistance in high-altitude mice, and to identify changes in gene expression and genetic regulatory networks that are responsible for adaptive enhancements of physiological performance in hypoxia.